Challenges in Natural Language Processing for Clinical Narratives

DESCRIPTION (provided by applicant): Narratives of electronic health records (EHRs) contain useful information that is difficult to automatically extract, index, search, or interpret. Clinical natural language processing (NLP) technologies for automatic extraction, indexing, searching, and interpretation of EHRs are in development; however, due to privacy concerns related to EHRs, such technologies are usually developed by teams that have privileged access to EHRs in a specific institution. Technologies that are tailored to a specific set of data from a given institution generate inspiring results on that data; however, they can fail to generalize to similar data from other institutions and even other departments from the same institution. Therefore, learning from these technologies and building on them becomes difficult. In order to improve NLP in EHRs, there is need for head-to-head comparison of approaches that can address a given task on the same data set. Shared-tasks provide one way of conducting systematic head-to- head comparisons. This proposal describes a series of shared-task challenges and conferences, spread over a five year period, that promote the development and evaluation of cutting edge clinical NLP systems by distributing de-identified EHRs to the broad research community, under data use agreements, so that: * the state-of-the-art in clinical NLP technologies can be identified and advanced, * a set of technologies that enable the use of the information contained in EHR narratives becomes available, and * the information from EHR narratives can be made more accessible, for example, for clinical and medical research. The scientific activities supporting the organization of the shared-task challenges are sponsored in part by Informatics for Integrating Biology and the Bedside (i2b2), grant number U54-LM008748, PI: Kohane. This proposal aims to organize a series of workshops, conference proceedings, and journal special issues that will accompany the shared-task challenges in order to disseminate the knowledge generated by the challenges.

Public health relevance
Public health relevance: this proposal will address two main challenges related to the use of clinical narratives for research: availability of clinical records for research and identification of the state of the art in clinical natural language processing (NLP) technologies so that we can push the state of the art forward and so that future work can build on the past. Progress in clinical NLP will improve access to electronic health records for research, and for clinical applications, benefiting healthcare and public health. __SpecificAimsTextDelimiter__ Challenges in Natural Language Processing for Clinical Narratives Specific Aims: This proposal aims to organize a series of five annual workshops, workshop proceedings, and journal special issues for the dissemination and sharing of the new knowledge created during the annual clinical NLP shared-task challenges co-sponsored by Informatics for Integrating Biology and the Bedside (i2b2), grant number U54-LM008748, PI: Kohane. For each of the annual shared-task challenges, a set of EHRs is made available to the research community along with specific clinical NLP research goals. These research goals consist of cutting-edge NLP tasks that can improve access to information in the narratives of EHRs. The set of EHRs to be used for each shared-task challenge are de-identified and hand-annotated for the gold standard on the task. A subset of the annotated records is made available to the research community for system development; and the rest are held out as an evaluation set. All systems are evaluated on this held out set. A common evaluation data set for all research targeting the same shared-task challenge enables identification of the state-of-the-art in that task, gives direction to future research, and encourages practical applications that benefit from the state-of-the-art. Therefore, as a part of this proposal, we aim to: 1. Distribute de-identified EHRs to the research community under data use agreements so as to enable system development and evaluation on a selection of cutting-edge clinical NLP tasks. The lessons drawn from the systems developed for each shared-task pave the way for the advancement of the field. Therefore, given the data and the shared-task topic, we propose to: 2. Organize annual workshops for the presentation of the systems developed for the shared-tasks to the research community, and 3. Organize annual publications, in the form of workshop proceedings and journal publications, that disseminate the scientific findings of the shared-tasks to the research community.